Pain Management Collaboratory Coordinating Center (PMC3)

NIH-DOD-VA Pain Management Collaboratory Coordinating Center
Administrative Supplement
Project Summary / Abstract Original
The Pain Management Collaboratory Coordinating Center (PMC3) will (1) provide national leadership and
technical expertise in all aspects of research supporting the design and execution of high impact
Demonstration Projects that conduct cost-effective, large-scale, pragmatic clinical trials on nonpharmacological
approaches for pain management and other comorbid conditions in veteran or military health care systems,
and (2) make data, tools, best practices, and resources from these and other projects available to facilitate
research partnerships in VA and DOD health systems. The PMC3 will leverage the expertise of the Pain
Research, Informatics, Multimorbidities and Education (PRIME) Center of Innovation based at the VA
Connecticut Healthcare System (VACHS) and its partners at VACHS and Yale, including the VA Cooperative
Studies Program Coordinating Center/Clinical Epidemiology Research Center and the Yale Center for
Analytical Sciences and Yale Center for Medical Informatics, enhanced by a strong partnership with colleagues
at the Uniformed Services University for the Health Sciences Center for Rehabilitation Sciences Research and
a novel Military Treatment Facility Engagement Committee comprised of collaborating DOD and university
affiliated investigators, clinicians and educators devoted to facilitating successful pragmatic trials in DOD
settings. We will use our expertise in pain management, electronic health records (EHR), data systems and the
design and coordination of multi-site pragmatic trials to accomplish these objectives in collaboration with our
VA, DOD and Yale partners. To achieve these objectives, three specific aims for this supplement will be
addressed: Aim 1: To engage new projects in employing lessons learned and best practices; Aim 2: To support
the design and execution of new demonstration projects; and Aim 3: To increase focus on refinement and
enactment of Dissemination & Implementation plans. Achievement of these objectives and Specific Aims
promise to significantly accelerate the integration of evidence-based nonpharmacological approaches for the
management of pain and common co-occurring conditions into routine clinical care in military and veteran
health care systems consistent with key recommendations from the National Pain Strategy.

Public health relevance
PROJECT NARRATIVE The Pain Management Collaboratory Coordinating Center (PMC3) will (1) provide national leadership and technical expertise in all aspects of research supporting the design and execution of high impact Demonstration Projects that conduct cost-effective, large-scale, pragmatic clinical trials on nonpharmacological approaches for pain management and other comorbid conditions in veteran or military health care systems, and (2) make data, tools, best practices, and resources from these and other projects available to facilitate research partnerships in VA and DOD health systems. We will use our expertise in pain management, electronic health records (EHR), data systems and the design and coordination of multi-site pragmatic trials to accomplish these objectives in collaboration with our VA, DOD and Yale partners.